Modeling Histone Demethylase Function in Neurogenesis

ABSTRACT
Cortical development is dependent on the coordinated expression of critical genes for proper cognitive
function. Alterations in expression of these key genes during development can result in complex
neurological diseases. Epigenetic mechanisms dynamically regulate expression of key genes and their
loss of function disrupts cortical development and contributes to brain disorders. Rare pathogenic
mutations in one epigenetic factor, KDM3B, are linked to intellectual disability and autism spectrum
disorders (ASD). This exploratory proposal will test the functional consequences of these KDM3B
mutations on cortical development using human embryonic stem cells with mutations of KDM3B. We
will investigate both cellular and molecular differences between mutant and control cells as they
differentiate into neural progenitor cells and neurons. Integration of these cellular data with molecular
data will reveal the direct effects of intellectual disability related mutations in KDM3B to
neurodevelopment.

Public health relevance
PROJECT NARRATIVE The proposal is aimed at investigating the molecular and cellular mechanisms of the role of a key epigenetic factor, KDM3B, in human cortical development. This exploratory proposal will test the functional consequences of KDM3B mutations known to be causative for intellectual disability and autism spectrum disorders on cortical development from human embryonic stem cells.